The effect of endogenous and exogenous glucocorticoids acting through regulatory T cells on resolution of ALI and the contribution of host genetic variability.

Project Summary
Critical questions remain regarding the recovery of lung structure and function following acute respiratory
distress syndrome (ARDS) and pneumonia. A subset of immune cells, Foxp3+ regulatory T lymphocytes (Tregs),
are essential in resolving inflammation for several experimental models of acute lung injury (ALI). Furthermore,
several groups, including ours, have established that Tregs are present in the lungs of patients with ARDS,
suggesting Tregs contribute to recovery during ARDS. While therapies are limited for ARDS, several trials have
illustrated the mortality benefits of glucocorticoid (GC) therapy for ARDS and pneumonia. The mechanistic
effects of GC are pleiotropic, and their influences on Treg phenotype and function are varied and remain ill-
defined during ARDS. Furthermore, the heterogeneity of patient responses to GC and the contribution of the
etiology and severity of the illnesses, the timing of therapy, and the dosage of GC to GC's efficacy all merit more
investigation. Our published studies in murine ALI demonstrate that during the resolving phase of lung injury,
Tregs expand in number and change their gene expression profiles compared to Tregs in uninjured control lungs.
Treg transcriptome profiles suggest changes in gene expression that may contribute to Treg-driven lung repair.
One transcript upregulated in Tregs isolated from resolving lung tissue is the glucocorticoid receptor (GR)
(Nr3c1). Our Aims seek to test the hypothesis that glucocorticoid signaling occurs through Tregs, and this Treg-
signaling is critical to GC effects. Aim 1 proposes to determine the function of Treg’s GR signaling and the direct
and indirect impact of GCs on Treg-promoted resolution. We hypothesize that the administration of exogenous
GC affects Treg responses during resolution. Additionally, we will test the hypothesis that GR-deficient Tregs
have decreased immunomodulatory and tissue reparative effects during ALI. Aim 2 addresses the effects of host
genetic variations on the functions of Tregs and the effects of GCs. Host genetic variation likely impacts on the
immunologic response during ARDS and are determinants of outcomes. The Collaborative Cross (CC) is a multi-
parental genetic reference population generated using eight founder mouse strains. These genetically diverse
CC strains demonstrate phenotypic variability useful for genetic mapping disease trait-associated quantitative
trait loci (QTL). Variation in Treg phenotypes in the CC has been reported. Aim 2 proposes leveraging the CC's
genetic diversity to test the hypotheses that 1) host genetic variation impacts the response to exogenous GC
administration after inducing ALI and 2) variation in the Treg number or effector phenotypes across the CC
associates with different rates of resolution of ALI and identifies genetic loci that define genes of host variation.
We predict that the proposed studies will identify genetic loci that modulate Treg responses critical in resolving
ALI and will identify the role of GCs in promoting resolution. Identifying and elucidating these mechanisms of GC
action and GR function may identify possible therapeutic approaches to lessen collateral tissue damage without
negatively altering the response to injury.

Public health relevance
Project Narrative Our research addresses critical questions regarding the recovery of lung structure and function following acute respiratory distress syndrome (ARDS) and pneumonia, and the specific immune cell types and their functions in lung recovery. Regulatory T Cells (Tregs) promote resolution of lung injury through changes in their transcriptome, which includes increased expression of the glucocorticoid receptor during resolution. We propose to identify the effects of endogenous and exogenous glucocorticoids acting through Tregs on the resolution of lung injury and the contribution of host genetic variability through which Tregs promote reparative processes and their response to glucocorticoids, which may uncover new targets to help accelerate lung repair and recovery for ARDS patients.